Evolution of pleiotropic consequences via mucoid phage resistance in Escherichia coli populations

PROJECT SUMMARY
Pleiotropy, which occurs when a genetic change alters two or more phenotypes, can be observed during
pathogen evolution when resistance to one treatment results in sensitivity to another treatment. Prior research
suggests that bacteriophage-based alternatives to antibiotics can be more effective when phage resistance
comes at a cost to bacterial virulence, but the molecular mechanisms of pleiotropy are often uncharacterized.
One common phage-resistance mechanism, mucoidy, occurs through over-production of exopolysaccharide,
creating a physical barrier between the cell and phage. As a virulence factor for many pathogens, mucoidy is of
interest to the medical applications of phages as well as the study of naturally occurring phages. The objective
of this application is to test predictions about the pleiotropic side effects of mucoid-based resistance to a
candidate therapeutic phage. The hypothesis is that the evolution of mucoidy will be constrained based on
genetic and environmental conditions. The rationale is that resistance to phages reliably arises by evolution, but
that different phage-resistance mutations incur different costs in different environments, as shown throughout
the preliminary data. The long-term goal is to apply evolutionary principles to use phages to not only to kill target
host bacteria, but to also evolutionarily ‘steer’ bacterial populations towards a less pathogenic state via pleiotropic
mutations. The research objective will be met through three Specific Aims: (1) Identify how the host strain
impacts the evolution of mucoidy-based phage resistance. (2) Characterize the pleiotropic effects between
mucoidy, antibiotic resistance, and motility. (3) Test how environmental spatial structure and antibiotic presence
impact the evolution of mucoidy. The proposed work is innovative because it will: (a) Leverage details about the
molecular genetics of mucoid phage resistance to generate hypotheses about evolution. Preliminary data details
the mucoid mutations through the E. coli Rcs phosphorelay, which also regulates other virulence factors. (b)
Assess the potential for mucoidy to be a barrier or asset to phage therapy in phage U136B. Phage U136B relies
on the TolC antibiotic efflux pump protein as a receptor, driving a pleiotropic tradeoff between antibiotic and
phage resistance. (c) Test how bacterial genetic background influences the evolution of phage resistance. The
applied significance is understanding the balance between the challenges and opportunities of phage
resistance, which is crucial to the responsible use of phage therapeutics. The fundamental significance is
understanding how bacterial evolution is constrained by pleiotropy in different genetic and environmental
contexts. This project significantly impacts undergraduate research by providing excellent mentorship,
supplies, and salaries for six undergraduate researchers. The PI has a highly established record of
undergraduate mentorship, co-authorship, awards, research-based pedagogy, and focused one-on-one
mentorship. The proposal presents substantial preliminary data collected by undergraduates, and
undergraduates will be involved in all proposed work.

Public health relevance
PROJECT NARRATIVE Bacteria are increasingly evolving resistance to antibiotics due to selection pressure in clinical settings. Characterizing the mechanisms of alternative treatments is crucial to reducing the prevalence of untreatable infections. This study investigates the impact of lytic bacteriophage on bacterial virulence and antibiotic- resistance factors.